Biophysical Basis of Functional Connectivity by MRI

SUMMARY / ABSTRACT
This is a 1st competitive renewal of our project “Biophysical Basis of Resting State Connectivity by MRI”.
Our goals are to determine whether inter-regional correlations in resting state fluctuations of MRI (rsfMRI)
signals from the brain reliably measure functional connectivity (rsFC) between brain regions, and to establish
how MRI data correlate with other metrics of connectivity. These goals are directly relevant for the validation
and interpretation of human applications of rsfMRI. Studies performed to date have focused on mesoscopic
scale networks (100µm - 10mm) within a well defined functional region of primary somatosensory cortex (S1)
in non-human primates, where we can measure spatial patterns of resting state correlations at high resolution
and validate their interpretation with electrophysiological signals and anatomic tracers. In the next phase, we
aim to expand these studies to further establish the origins and significance of rsFC measurements.
Cerebral cortex exhibits a laminar structure, but the laminar distribution of rsFC is poorly understood. In
addition, whether the strong inference that rsfMRI correlations directly represent and link functional connectivity
extends beyond the fine-grained level of sub-regions in S1 to more macroscopic dimensions remains
unexplored. Moreover, recent studies of apparent slow variations of rsfMRI correlations suggest that the resting
state itself exhibits dynamic variations that may be of functional importance. We therefore propose three
specific aims: [1] to identify the origins of rsFC by measuring the connectivity patterns of rsfMRI signals across
and between cortical layers in sub-regions of S1, S2, thalamus and corresponding contralateral regions. We
will acquire fMRI data at 9.4T using vibrotactile stimuli to identify functionally distinct candidate areas of
activation in bilateral S1, S2, and thalamus, and measure resting state correlations between voxels within and
across layers in these regions: [2] to measure the effects of selective deprivation of spinal, thalamic, cortical
and inter-hemispheric inputs on rsfMRI and demonstrate their relationships to behavior: [3] to validate
measurements of rsFC signals in normal and input-deprived conditions by direct comparisons with quantitative
intracranial electrophysiology and histology. We will acquire rsfMRI and invasive multi-electrode measurements
in the same animals to quantitatively compare different metrics of neural activity and anatomical connections.
We will acquire fMRI data at 9.4T from monkey brain to study functionally distinct areas in SI, SII, and
thalamus. We will use innovative mathematical analyses to quantify variations in resting state correlations
across time and whether these patterns agree with slow variations in electrophysiological correlations. We will
perform invasive multichannel microelectrode array measurements in the same animals so that we can
quantitatively compare different metrics of neural activity and anatomical connections. We believe that the
proposed studies have considerable importance for validating the neural basis of resting state functional
connectivity measures, and have direct implications for human fMRI studies and their applications.

Public health relevance
Narrative Neuroscientists and clinicians currently use MRI to depict connectivity within neural circuits in the human brain by analyzing small signal ﬂuctuations that arise during acquisitions of long series of images while a subject is at rest. However, there have been very few studies that validate the interpretation of these signals and their biophysical origin has not been substantiated. The studies proposed would establish the relationships between these MRI metrics of connectivity and gold standard electrophysiological recordings of neural electrical activity and maps of anatomic connections from injected tracers in the brains of non-human primates.